Human iPSC neural spheroids to screen for compounds that block tau propagation

RESEARCH & RELATED Other Project Information
Novoron Bioscience, Inc.
7. PROJECT SUMMARY
Approximately 6.9 million people aged 65 and older in the United States have Alzheimer’s dementia (AD).1,2 AD
and other dementias are a major economic burden expected to cost $360 B in 2024, of which $231 B will be
funded through Medicare and Medicaid.3 There is an urgent need to identify and develop disease-modifying
therapeutics as current therapies only add 0.65 quality-adjusted life years and cost $130,000 per year.4,5
Tauopathies, including AD, exhibit prion-like neuron-to-neuron transsynaptic propagation of tau.6 Here, we
propose a platform-based strategy to evaluate novel therapies designed to inhibit the propagation and
aggregation of pathological tau. As part of this platform, we will use LRP1 (an established model known to
influence tau propagation) WT and KO human induced pluripotent stem cell (hiPSCs) derived neural organoids
to confirm that our system accurately detects changes in tau propagation. This robust, multi-faceted platform will
enable the identification and validation of candidates that disrupt tau pathology, providing a path toward new
treatments for AD and other tauopathies.
Our team and others have shown that organoids generated from hiPSCs serve as a scaled-down and three-
dimensional model of the human brain, mimicking various developmental features at the cellular and molecular
levels. Unlike animal models, which do not always translate to human utility, or other in vitro models, which
cannot capture the complexity of human tissues, organoids recapitulate aspects of in vivo brain development
and function in a dish. Organoids are recognized for their usefulness as a translationally valid organ-level
platform in the drug discovery space for colon cancer, cystic fibrosis, and precision therapy. Cortical organoids
have further proven to be informative models of human brain development, tissue organization and cell-cell
interactions, and maturation, suggesting a likely utility in therapeutic advancement. Cortical organoids retain
properties of a neural organ to a large degree, including integration of supporting cells, cytoskeletal structuring,
cellular organization into particular regions, and in some cases, in vivo-like spontaneous network activity. Our
team recently used Rett syndrome organoids to identify donepezil (approved for AD as Aricept) that is now
entering a DOD-funded Phase II clinical trial.
We will create LRP1 WT and KO organoids to optimize and validate the utility of the organoids in screening with
control compounds and the ability of the experimental small molecules to modulate tau propagation. This project
brings together the expertise of Novoron Bioscience, BrainStorm Therapeutics, and Defined Bioscience to
develop human-relevant brain models for drug discovery. By employing advanced hiPSC-derived cortical brain
organoid technologies, we aim to establish a scalable, high-throughput screening platform to identify small
molecules that disrupt tau-LRP1 interactions. The project addresses critical unmet needs in Alzheimer’s drug
development and will generate new insights into tau pathology mechanisms.

Public health relevance
RESEARCH & RELATED Other Project Information Novoron Bioscience, Inc. 8. PROJECT NARRATIVE Tau protein, which is dysregulated Alzheimer’s disease, does not have any small molecule drugs to limit its propagation. Organoids generated from LRP1 (low-density lipoprotein receptor-related protein WT and KO human induced pluripotent stem cells (hiPSCs) provide a scaled-down and functional three-dimensional model of the human brain, mimicking various developmental features at the cellular and molecular levels. We will use this high-throughput screening compatible platform to test control and experimental drugs to address dementias associated with tau propagation via LRP1, enabling a slowing and potential prevention of tauopathy hallmarks in AD.